Unraveling the Connection: How Metabolism Shapes Mammalian Persister Survival

UNRAVELING THE CONNECTION: HOW METABOLISM SHAPES MAMMALIAN PERSISTER SURVIVAL
Summary
Our overall goal in this research project is to evaluate the role of metabolism in persister cell survival in
mammalian cell populations. Persister cells are defined as a small fraction of quiescent cells in a tumor bulk
population that exhibit temporary tolerance to drugs. These cells are an important health concern because they
are thought to underlie the proclivity of recurrent tumors to relapse, and they serve as a reservoir from which
drug-resistant mutants can emerge. Due to their transient state, persisters possess the capacity to revert to a
state of growth and produce drug-sensitive daughter cells; however, their physiological properties underlying
entry into and exit from this quiescent state remain unclear. The central hypothesis of this proposal is that
persisters have a transient metabolic state characterized by increased oxidative phosphorylation and decreased
anabolic activities. Our previous studies indicate that transient metabolic rewiring in persisters is largely induced
by chemotherapeutic agents, which may result from the inhibition of cell growth. In our 1st Aim, we will verify our
hypothesis through the use of persister assays, proteomics, metabolomics, redox sensors, phenotype
microarrays, and a range of mammalian cell types and chemotherapeutic agents. By utilizing fluorescence
microscopy and fluorescent reporters, we will uncover the metabolic dynamics of persister cells through the
examination of individual cell trajectories during and after drug treatment. In our 2nd Aim, we plan to uncover the
active metabolic pathways and their significance in persisters through a combination of experimental data and
mathematical models. Our mathematical approach will involve utilizing optimization programming with various
objective functions to assign weight values for each metabolic pathway. The models will take into account the
topological properties of the metabolic network, as well as constraints such as reaction rates, thermodynamics,
and other regulatory mechanisms. By comparing the results of multiple models, we will identify the common or
unique crucial features. Our hypothesis is that a metabolic pathway that is consistently identified as significant
through different models will play a crucial role in the survival of persister cells. Our hypothesis will be tested by
disrupting the targeted pathways through genetic and chemical means. The proposed research program is
expected to have a substantial impact for the following reasons: (i) There is an ongoing debate about whether
dormant, quiescent, tolerant, and persister cells in tumors are the same population or related to tumor stem cells.
Despite this uncertainty, the existence of a small fraction of phenotypes that survive initial treatments is
undisputed, and this should raise significant concerns within the medical community. (ii) Our approach uniquely
combines experimental results with computational models to identify unknown biochemical pathways driving
persister cell metabolism. (iii) The proposed research will have a broader impact as the methods developed here
will be applicable to persister cells in diverse mammalian and microbial organisms.

Public health relevance
NARRATIVE This research program aims to comprehend the metabolic mechanisms behind mammalian persister phenotypes that are temporarily tolerant to drugs. A comprehensive approach that combines both experiments and mathematical modeling will be used to identify active metabolic pathways and evaluate their importance. The expected outcome is to uncover metabolic targets that can be potentially utilized in therapy to eradicate persister cells.